Stepped care to optimize PrEP effectiveness in pregnant and postpartum women (SCOPE-PP) in South Africa

PROJECT ABSTRACT OF PARENT AWARD (R01HD106862)
New maternal HIV infections contribute significantly to vertical HIV transmission underscoring the
urgent need for primary prevention interventions for high-risk pregnant and breastfeeding women. Pre-
exposure prophylaxis (PrEP) in pregnancy and breastfeeding is safe and effective at preventing HIV. However,
PrEP adherence and continuation remain low in pregnancy, and drop precipitously in the postpartum period.
Our team is made up of experts in epidemiology, behavioral science, health economics and implementation
science from University of California Los Angeles and the University of Cape Town. Together we implemented
one of the first studies to integrate PrEP into antenatal care in South Africa (“PrEP-PP”; R01MH116771), that
will end enrollment in 2022. Leveraging the research findings to date, we propose to test a novel strategy to
optimize PrEP in pregnant and postpartum women in South Africa. Our randomized control trial (RCT) is
designed to address key barriers to maternal PrEP use and evaluate cost-effectiveness to inform national
policy. This trial builds on our earlier work demonstrating the acceptability, feasibility, safety and potential
efficacy of a package of interventions including: 1) Rapid PrEP; 2) Enhanced biofeedback counseling; and 3)
Choice of community PrEP delivery for women who show poor PrEP continuation (miss 1+ PrEP pick-up, and
wish to continue on PrEP). We developed and piloted a novel intervention entitled, Stepped Care to Optimize
PrEP Effectiveness in Pregnant and Postpartum women (SCOPE-PP) that addresses barriers to taking daily
PrEP by streamlining PrEP access and empowering women to adhere to PrEP. We will evaluate SCOPE-PP in
a pragmatic RCT of pregnant and postpartum women at risk of HIV acquisition. We will enroll 500 pregnant
women in antenatal care and follow them through 12-months’ postpartum. Women in the intervention will be
offered: Step 1: Rapid PrEP collection with enhanced biofeedback counselling using a novel urine assay that
measures recent PrEP adherence, and Step 2: Community PrEP delivery for women who miss PrEP pick-up
visit, to de-link PrEP from clinical visits. The primary outcome is PrEP adherence in postpartum women,
measured through drug levels of tenofovir diphosphate. We aim to: 1) Evaluate the efficacy of the SCOPE-PP
intervention on PrEP adherence in pregnant and postpartum women in a RCT; 2) Assess barriers and
facilitators to the integration of SCOPE-PP package into ante- and postnatal care using the Consolidated
Framework for Implementation Research; and 3) Estimate the cost effectiveness and equity impact of SCOPE-
PP vs. standard of care per HIV infection and disability-adjusted life-year averted. This research is critical to
inform maternal PrEP interventions to eliminate HIV acquisition and vertical transmission in high HIV burden
communities and inform national policies to roll out maternal PrEP services.

Public health relevance
PROJECT NARRATIVE Despite significant public health developments, pregnant and postpartum women in South Africa remain at high risk for two interrelated phenomena: acquiring HIV and being a victim of intimate partner violence (IPV). Pre-exposure prophylaxis (PrEP) is one of the only female-controlled methods effective for preventing HIV acquisition; yet, PrEP adherence and continuation remains very low among this population. We seek to better understand the risk factors for experiencing IPV, how this influences PrEP adherence and continuation, and impacts birth outcomes in our study population to help further develop targeted interventions to help identify at risk women to mitigate the risk of adverse pregnancy outcomes for both the mother and the infant.